LitCog V: Health Literacy and Cognitive Function Among Older Adults

We seek to renew our longstanding cohort study, known as `LitCog' (R01AG030611), and culminate
investigations of cognitive function trajectories among older adults and their involved caregivers.
Since 2007, the LitCog study has examined the confluence of increased medical morbidity with older age that
results in more complex patient self-management (SM) roles, and cognitive decline that may adversely affect
older adults' health literacy (HL) skills, chronic illness self-care, and functional independence. Initially a cross-
sectional study (LitCog I), adults ages 55-74 were recruited from community-based, primary care practices
throughout Chicago. Participants completed comprehensive cognitive, psychological, social, behavioral, and
functional health assessments (`T1' interview). LitCog became a cohort study with 3 renewal awards (LitCog II,
III, IV); follow-up assessments have been conducted every 3 years (T2-T6). Our research has shown how
cognitive function determines one's HL, that both decline together over time, and declines in certain cognitive
domains adversely impact SM skills, treatment adherence, functional health status, and chronic disease
outcomes. Modifiable psychological, behavioral, and social risk factors for cognitive decline have been identified.
Initiated by an administrative supplement and expanded in this funding cycle (LitCog IV), a `LitCog Caregiver'
cohort is now established; 3 caregiver interviews (aligned to T4-T6) have examined the presence, skills, and
evolving support provided by caregivers, and whether / how their involvement has benefited LitCog participants.
We now seek a LitCog V renewal that will add a T7, T8 assessment and 2 additional caregiver interviews.
After 15 years, patient and caregiver participants remain available for further study. With 8 patient assessments
over 2 decades, we are well-poised to assess the prevalence of and adjustment to increasing morbidity, disability,
cognitive impairment (CI), and dementia. Trajectories of cognitive function, HL, SM skills, health behaviors,
physical/mental health, clinical outcomes, healthcare use and mortality can be better modeled. With 5 parallel
caregiver interviews over 12 years, caregiver determinants of patient health outcomes can be more precisely
investigated. Costs of cognitive decline, CI and dementia will also be explored, responding to NIA priorities.
Our specific aims are to: 1) finalize investigations of trajectories of cognitive function, HL, and SM skills, and their
determinants, over a 20-year span among older adults; 2) determine the prevalence of CI and dementia and
identify factors associated with its detection, diagnosis, and ongoing management; 3) investigate health
management support roles among caregivers over 12 years; 4) estimate the direct and indirect costs of cognitive
decline, cognitive impairment, and dementia from a local patient, caregiver, and health system perspective.
LitCog V will be a capstone to our investigations into age-related cognitive changes with increasing
comorbidity, and modifiable factors that may offset the impact of cognitive decline on health outcomes.

Public health relevance
PUBLIC HEALTH NARRATIVE The number of adults over 65 is expected to double by 2050, and health systems will be caring for more older adults who have multiple chronic conditions, including Alzheimer's disease and related dementias (ADRD), and thus declining capacity to adequately participate in healthcare and manage personal health. Our LitCog study will follow older adults for 20 years and involved caregivers for 12 years; uniquely capturing cognitive trajectories and elucidating potentially modifiable factors (including caregiver involvement and roles) that may inform the design of health system strategies to mitigate the impact of cognitive decline / impairment on health outcomes.